Integrating Continuous Glucose Monitoring in Diabetes Self‐Management Education and Support toImprove Glycemic Control in Latino Adults with Type 2 Diabetes

Project Summary/Abstract: Dr. San Diego is a social and behavioral scientist with a strong foundation in using community-based participatory research (CBPR) and clinical and translational sciences. As an Early-Stage Investigator, her research is focused on using a socioecological perspective to adapt type 2 diabetes (T2D) self-management programs to address individual, social, and environmental factors that influence health outcomes. As such she is pursuing a research career combining CBPR and implementation science to improve digital health outcomes in populations experiencing high prevalence of T2D complications and may benefit from newer treatment approaches. The proposed research aims to: 1) understand barriers and facilitators to CGM device uptake and maintained use by conducting a needs assessment with patients, diabetes educators, clinicians, and health plan administrators; 2) integrate education of CGM device in the Project Dulce diabetes education curriculum (CGM + PD) and develop implementation strategies using implementation mapping; and 3) pilot test CGM + PD in improving CGM metrics in insulin-treated adults (N=72) with T2D across 6 months. The K01 career development plan supports the research aims and Dr. San Diego’s transition to independence with training in 1) building sustainable network and community partnerships; 2) implementation science; 3) CGM implementation and data evaluation; 4) rigorous qualitative and advanced quantitative statistical methodologies; 5) leadership skills to execute multi-center studies; and 6) grant writing for a large, multi-site study. She will be supported by a strong mentoring team, including Dr. Athena Philis-Tsimikas (primary mentor), an expert in team-based diabetes care, community-engaged research, and integrating diabetes technologies into real-world healthcare settings; Dr. Amisha Wallia, a physician scientist with expertise in health research, diabetes technologies, and multi-site trials; Dr. Michael I. Goran, an expert in clinical, behavioral, and community approaches to T2D treatment and risk reduction; Dr. Beth Pyatak, an occupational scientist with expertise in qualitative methods and implementation science research; Dr. Jill Waalen, a biostatistician with expertise in CGM data analysis; and Dr. Barbara J. Turner, an expert in dissemination and implementation science and community-engaged research. Dr. San Diego’s overarching goal is to improve the quality and quantity of life of populations burdened by T2D. Scripps Health is an ideal environment for her to accomplish her training and career goals given its clinical settings that offer health care and access to various populations in San Diego, CA, and is committed to providing her with protected time and resources needed to successfully complete her study. Importantly, this award will provide her with protected training time to build on her existing skills in CBPR and advance her knowledge in implementation science and diabetes technologies so that she can conduct studies that promote the adoption and integration of digital health devices in real-world settings.

Public health relevance
Project Narrative: Despite the demonstrated benefits of continuous glucose monitoring (CGM), a critical gap exists in our understanding of sustainable and real-world approaches for integrating CGM into routine self-management in adults with type 2 diabetes (T2D). The proposed study aims to: 1) identify barriers and facilitators to CGM use in T2D by conducting a needs assessment; 2) integrate education and training of CGM device in an evidence-based diabetes self-management education and support (DSMES) program; and 3) pilot test the adapted program in improving CGM metrics and glycemic outcomes in N=72 insulin-treated adults with T2D. We posit that supplementing the initiation of CGM device use with a structured education program via DSMES that is responsive to patient needs and preferences will lead to improved CGM device uptake and improved clinical and behavioral outcomes.